ASEHL Special Project, NFSDX and ORAPP Integration

ASEHL Project Summary-NFSDX SFY2021 The NFSDX and ORAPP Integration project facilitates new programming, modifications, and enhancements to export data from our LIMS for distribution to FDA. The clients, including the Alaska Food Safety and Sanitation (FSS) Program and U.S. FDA, will benefit by receiving enhanced simultaneous and direct communications with actionable data regarding food safety issues. ASEHL will mostly utilized in-house IT personnel to develop and test electronic data deliverables. However, it is expected that some assistance in custom programing from the LIMS vendor may be needed.